Single Domain Anti-Tau Antibodies as Potential Therapy for Alzheimer's Disease

Immunotherapies targeting various protein aggregates such as amyloid-β (Aβ), tau and α-synuclein are in different stages of clinical development, and collectively are the most common approach by the pharmaceutical industry to tackle diseases characterized by such depositions [13-15]. The majority of these approaches involve whole antibodies and much less attention has been paid to antibody fragments which have certain advantages and their therapeutic and diagnostic potential should be explored further. Specifically, single domain antibodies (sdAbs) are of particular interest because their small size (13 kDa) improves tissue penetration, including through the blood-brain-barrier, allowing better access over antibodies (150 kDa) to the target molecule and its hidden epitopes. Importantly as well, they are high affinity, and easy to engineer and grow in large quantities. The Specific Aim is to determine the therapeutic potential of camelid single-domain heavy chain antibody fragments (sdAbs) against the tau protein. It is hypothesized that their small size will provide therapeutic benefits over whole antibodies, primarily because of greater access to the target, and to some extent due to their binding to novel epitopes. We have generated 150 clones of sdAbs that recognize various forms of the tau protein and propose to determine their therapeutic potential in various models. For the initial screen, up to 40 of the individual sdAbs will be expressed globally in neurons of fruit fly models of tauopathy, and their ability to prevent/attenuate the tauopathy monitored. Subsequently, the 5 most efficacious sdAbs will be examined further in flies by expressing them in astrocytes or peripherally, and in cell culture models of tauopathy and the most efficacious one in an animal model. Our preliminary data supports the feasibility of screening for therapeutic efficacy of antibody fragments targeting the tau protein in fly models. Specifically, we show that neuronal expression of an anti-tau single chain variable antibody fragment (scFv) prevents developmental toxicity of overexpression of human tau with or without a tauopathy mutation, and significantly extends the life span of the tauopathy flies. The proposed studies may identify a novel class of therapy candidates for Alzheimer's disease, with direct relevance to various other protein misfolding disorders.

Public health relevance
The purpose of this project is to assess the efficacy of novel potential therapies for Alzheimer's disease and related tauopathies. The proposed studies may also enhance our understanding of tau pathogenesis. Hence, this research is very relevant to public health.